Corneal and Schwann cell mechanisms in vesicant injury

Abstract
Chemical threat agents can potentially be weaponized to cause mass casualties. The warfare agent sulfur
mustard and its chemical analog nitrogen mustard (NM) cause severe injury to ocular tissues with acute
epithelial defects, pain and delayed onset of keratitis. As yet, a comprehensive understanding of the cellular
contributors and pathophysiological molecular mechanisms of corneal pathology and sensory dysfunction
is lacking. Recently, we have described remarkable changes in citrullination, a protein posttranslational
modification (PTM), manifests in NM-injured murine corneas. Citrullination is catalyzed by peptidyl
arginine deiminases (PADs). Our preliminary findings show that PAD4 could be driving citrullination in
the corneal epithelium and stroma, but its citrullinated targets have yet to be formally identified. In addition,
it is still unclear how vesicant injury affects corneal sensory function and what molecular pathways in
corneal Schwann cells (cSCs) contribute to axonal degeneration and regeneration. To study such complex
facets of corneal pathology- structural integrity and sensory function – in this R01 grant proposal, we will
investigate the epithelium and sensory system, using citrullinomics and transcriptomics approaches,
respectively. Specifically in Aim 1, we will investigate what proteins are temporally altered by PAD4-
driven citrullination to illuminate biological pathways and cellular processes affected by citrullinated
proteins. These protein hits will be validated and assayed for function in human corneal epithelial cell
culture experiments. In Aim 2, we will focus on a newly identified druggable target in cSCs whose
pharmacological inhibition in NM injury promotes cSCs and axonal network regeneration and sensory
recovery, and hence understanding this SC-target’s mechanisms in cSCs would be important. We will
exploit a single nuclear RNA sequence analysis paradigm to pursue temporal transcriptomic changes
occurring in injured corneas to illuminate novel effectors of this regenerative paradigm. Bioinformatic
approaches will be used to interrogate these data to achieve a comprehensive overview of the pathways
affected by citrullination mediated by PAD4 in the cornea, and a similar decoding of transcriptomic
information for understanding cSC regenerative function. Ultimately, this two-pronged approach could
illuminate new biomarkers and effectors of corneal injury and unravel repair mechanisms that have not
been previously established.

Public health relevance
We will combine the use of transgenic and gene knockout systems with proteomic and transcriptomic approaches to study chemical injury in the cornea and interrogate these findings to illuminate new biomarkers and effectors of corneal injury and unravel repair mechanisms that have not been previously established.